Identifying the Structural Adaptations that Drive the Mechanically Induced Growth of Skeletal Muscle

Project Summary / Abstract
Per instructions, the project summary/abstract is included in the research strategy section of this application.

Public health relevance
Project Narrative A project narrative is not required for this Diversity Supplement.